Affective and Cognitive Changes in Alcoholism

[unreadable] DESCRIPTION (provided by applicant): This application is for the renewal of a Senior Scientist Award (SSA) under NIAAA sponsorship. In keeping with the goals of the prior term of the SSA, its renewal would permit the PI to continue to: (a) devote all of her research efforts to alcoholism, (b) participate in structural and functional neuroimaging in the study of alcoholism-related brain abnormalities, and (c) provide mentoring to women scientists. In conjunction with our recently funded R01 AA007112, we will continue to examine the interacting effects of alcoholism and gender on affective (emotional) and conative (intentional) functions. We will assess alcoholism-related vulnerabilities and dysfunction in fronto-limbic brain systems related to emotion, reward, and intention. In combination with psychophysiological monitoring and behavioral testing, we will utilize fMRI to probe responses to affective stimuli. Thus, peripheral electrodermal activity will be recorded concurrently with central hemodynamic (fMRI) changes in order to examine the coupling between autonomic and central measures during emotional activation. Structural MRI analyses will include morphometric assessment of brain structures involved in these fronto-limbic emotion and reward circuits, and diffusion tensor imaging (DTI) will be applied to assess coherence of white matter tracts connecting frontal regions with limbic, ventral striatal, and posterior cerebral systems. These experiments will probe the effects of chronic alcoholism on emotional perception, modulation, and memory. We will focus on brain structure and function underlying these neurobehavioral domains, as well as gender effects in association with alcoholism. Participants will be abstinent alcoholic men and women, ages 18-50, and nonalcoholic men and women group-matched on age, education, and IQ. The fMRI experiments will involve varying both the emotional content of the materials presented (emotional words and pictures), and the type of cognitive ability needed for task performance. Of particular focus in the imaging studies are fronto-limbic regions of interest (ROIs) tied to affective and conative functioning, regions we hypothesize to be associated with neuroanatomical, psychophysiological, and neurobehavioral deficits in alcoholism. Overall, we aim to sharpen distinctions among neurobehavioral sequelae of alcoholism in men and women, and to contribute valuable information about the neurobiology of cognitive aspects of emotion and intention deficits in alcoholism. [unreadable] [unreadable] [unreadable]